Ultra-low Fouling and Anti-infective and Anti-thrombotic Nitric Oxide Releasing Intravascular Catheters

ABSTRACT
Nytricx, Inc. (C Corp. registered in GA) is the recent recipient of a Phase II STTR NHLBI
administered grant application (Award Number: 2R42HL149595-02A1, project period 05/01/2020
to 07/31/2025). The title of the funded application is “Ultra-low Fouling and Anti-infective and Anti-
thrombotic Nitric Oxide Releasing Intravascular Catheters.” Indwelling vascular catheters are
prone to two major medical complications: thrombosis (blood clots) and infection immediately
after its insertion. Despite a crowded market and decades of research, a truly dual non-
thrombogenic and antibacterial surface has yet to be commercialized. Nytricx has recently
recruited and hired a US Citizen and minority candidate, Ms. Pravalika Irukulla, BS, MS in
Biological Engineering for their UGA Innovation Gateway leased research space at 220 Riverbend
Road, Room 027, Athens, GA 30602. Ms. Irukulla started her full-time employment with the
Company on September 21, 2023 and her job title is Research Associate I. Her major
responsibilities are to perform bench top fabrication of anti-infective Nitric Oxide (NO) releasing
intravascular catheters, determine catheter stability and release kinetics of NO gas from various
catheter polymers employed in loading of NO donors into intravascular catheters, determine the
antimicrobial efficacy of NO-releasing intravascular catheters in vitro and in vivo, determine the
anti-thrombotic efficacy of NO-releasing intravascular catheters in vivo, maintain the Company
research laboratory in high operating fashion, and order and inventory all supplies required by the
laboratory for the research work to be contemplated and completed.

Public health relevance
NARRATIVE Nytricx, Inc. has recently recruited and hired a US Citizen and minority candidate, Ms. Pravalika Irukulla, BS, MS in Biological Engineering to perform the laboratory research work described in the funded Nytricx Phase II STTR (Award Number: 2R42HL149595-02A1, project period 05/01/2020 to 07/31/2025). The title of the funded application is “Ultra-low Fouling and Anti- infective and Anti-thrombotic Nitric Oxide Releasing Intravascular Catheters.”